Small molecule induced proteolytic destruction of intrinsically disordered proteins

The significance: There are still no effective treatments for neurodegenerative diseases,
including Parkinson's and Alzheimer's disease and Alzheimer's related dementias.
The problem: The pathogenesis of these disorders are driven in large part by the toxic
signaling of amassed intrinsically disordered proteins (IDPs), such as alpha-synuclein or
(phosphorylated)-tau, which have a high tendency to oligomerize and aggregate upon
accumulation. During healthy homeostasis, IDPs are rapidly degraded by the 20S
proteasome and thus are short-lived and in near undetectable abundance. As we age,
proteasome activity is reduced and IDPs accumulate, leading to toxic signaling and
aggregation, which are the hallmarks of many neurodegenerative diseases. These unfolded
IDPs lack defined binding pockets, which made them evade traditional drug discovery design
efforts and are therefore often deemed “undruggable”. Of all human organs and tissues, the
brain expresses one of the highest levels of IDPs, and amassed levels of these highly
disordered IDPs have been directly linked to neurodegenerative disorders. No effective
treatments to prevent, stop or reverse these disorders are currently available.
The solution: Enhancing 20S proteasome activity should restore healthy protein homeostasis
and prevent the accumulation of disordered proteins.
Our approach: Instead of inhibiting IDPs with a drug, we will induce their proteolytic
destruction. Our hypothesis is that we can limit the toxic accumulation of IDPs by
enhancing/restoring 20S proteasomal degradation using small molecules. This approach is
different from all previous attempts to target IDP-instigated diseases. Our new data indicates
that 20S proteasome enhancements exhibits selectivity towards the toxic, highly disordered
oligomerization/aggregation-prone IDPs over other proteins that merely containing disordered
regions. Moreover, our preliminary data shows that the treatments do not induce cytotoxicity in
cells treated at high dose or following chronic exposure to the enhancers. This is an unexplored
field in science and human health and we will be one of the first to determine the possibilities
and limitations of this new approach in this work.

Public health relevance
The goal of this work is to evaluate the use of small molecules to enhance the catalytic degradation of a specific class of “undruggable” proteins, referred to as intrinsically disordered proteins. When over-expressed, these disordered proteins are directly implicated in many human diseases, including neurodegenerative diseases such as Parkinson's and Alzheimer's disease and Alzheimer's related disorders. This work will critically evaluate this new approach in terms of its potential, as well as its limitations, as a completely new therapeutic strategy to treat these incurable diseases.